Cancer Center Support Grant

Abstract
The UCLA Jonsson Comprehensive Cancer Center Community Outreach and Engagement (JCCC COE) team
will collaborate with community partners, the Mixteco Indigena Community Organizing Project (MICOP) and
Antelope Valley Partners for Health (AVPH) to develop tailored multi-channel communication campaigns to
promote cancer screening and tobacco control in two predominately low-income Latinx communities. This
supplement application is in response to Track 2: General Population (30+ Years). MICOP was established in
2001 with a mission to aid, organize and empower the Indigenous immigrant agricultural community in Ventura
County, California. This is a high-need community that faces many obstacles to accessing health care including
linguistic barriers as many community members speak only their native non-written language and little Spanish
or English. The Antelope Valley (AV) extends across 3000 square miles and is one of the least densely
populated and most economically challenged areas of Los Angeles County, with relatively few health and social
service resources. AVPH is a non-profit community collaborative dedicated to improving the lives of the most
vulnerable and underserved in the AV, including individuals living in poverty, who have limited or no access to
health services. Proposed activities in collaboration with MICOP, which are expected to reach 50,000 residents,
will include radio campaigns, social media campaigns, and referral to cancer screening services at through local
safety net clinic partners. Activities targeting the Antelope Valley will reach an estimated 6,500 residents and
will include social media campaigns, trainings for AVPH community health workers, and referrals to cancer
screening services at local safety net clinics. Our JCCC COE team has decades of experience collaborating with
community organizations, including several prior joint initiatives with MICOP and AVPH. Both organizations
have deep ties to their communities and extensive knowledge and experience regarding the best ways to serve
community members. Receipt of this supplement will be instrumental in expanding our capacity to promote
cancer screening and tobacco control in the high-need Latinx communities served by these organizations. Our
proposed work is well aligned with the overarching mission of the JCCC and COE to reduce cancer disparities
through outreach and engagement activities with the most affected communities. We look forward to building
on lessons learned through this project to develop and disseminate similar campaigns with additional partners in
future years. Moreover, we will leverage our networks to disseminate project products and findings so that they
may serve communities across the state and nation.

Public health relevance
Public Health Relevance Through this supplemental funding award, the UCLA Jonsson Comprehensive Cancer Center Community Outreach and Engagement (JCCC COE) team will collaborate with community partners, the Mixteco Indigena Community Organizing Project (MICOP) and Antelope Valley Partners for Health (AVPH) to develop tailored multi-channel communication campaigns to promote cancer screening and tobacco control in predominately low-income Latinx communities in two high need regions served by the JCCC. Supplement activities are expected to reach over 50,000 residents and will include radio campaigns, social media campaigns, training of CHWs, and referral to cancer screening services. Receipt of this supplement will be instrumental in expanding our capacity to promote cancer screening and tobacco control in the high-need Latinx communities served by these organizations.